Decoding disease-critical genomic architecture using multimodal single-cell omics data

Project Summary/Abstract
Understanding the functional architecture of human diseases and traits at a cellular resolution is critical for
informing follow-up functional characterization experiments and nominating genes and pathways for developing
drug targets. Large scale omics data encompassing multiple modalities (RNA-seq, ATAC-seq, ChiP-seq), a
broad range of tissues and cell types, and diverse biological contexts, such as disease stages, developmental
trajectories, and gene perturbations, offer significant new resources to gain a deeper understanding of the
genetic architecture of complex diseases. In this proposal, we plan to develop statistical and machine
learning approaches that bridge the gaps between human genetics and single-cell omics data to
decode
the regulatory activity underlying disease variants, link variants to genes accurately in relevant cell
types of action, and identify disease-critical co-operative programs of genes and genomic elements
activated in specific biological contexts
. The proposed aims are targeted at uncovering new insights into
complex disease etiology by advancing our understanding of gene regulation and exploring the synergies and
contrasts in epigenomic activity and downstream cellular processes or biological pathways. A key goal of this
application is to produce a set of computational tools and workflows that can identify and rank functionally
disease-critical variants, genes, and pathways, along with a detailed understanding of their putative cell type
and biological context of action. This can greatly inform downstream disease-focused intervention strategies like
drug perturbation, and single-guide or combinatorial CRISPR screening experiments.
In the first aim of this proposal, we will leverage single-cell RNA+ATAC multiome data to learn improved
strategies of linking enhancers to genes in a cell type, explore the co-operative effects of multiple enhancers on
gene regulation, and identify sets of enhancers and linked genes that together constitute distinct disease-critical
functional units. In the second aim, we will use quantitative trait loci (xQTL) data spanning a broad range of
molecular phenotypes to map the cis and trans-regulatory architecture of GWAS variants, and better pinpoint
causal variants for these phenotypes through integration with base-pair resolution variant function assays and
models, such as sequence-based deep learning models. In the third aim, we will leverage multimodal omics
data observed across multiple biological contexts to identify programs of genes and elements activated under
specific contexts and assess their impact on complex disease GWAS signals. We will also demonstrate how
disease-related benchmarking of gene programs activated upon enhancer and gene perturbations can inform a
cost-efficient experimental plan of a downstream perturbation experiment with multi-omics readouts. All variant-
level functional annotations, variant-gene links, and gene programs, together with a quantitative and qualitative
assessment of their impact on human diseases, and all relevant computational software and pipelines will be
shared publicly with the scientific community.

Public health relevance
Project Narrative A vast majority of genetic variants associated with human complex diseases and traits are observed in the non- coding regions of the genome with potential effects on gene regulation. To generate actionable hypotheses informing drug design and functional characterization assays, it is critical to understand, for each disease-causal variant, a precise characterization of its regulatory activity in terms of transcription factor binding, methylation, or histone marks, its likely target gene of action, the downstream gene pathways it impacts, and the cell types and biological contexts underlying the activity of this variant. My proposed research plan aims to integrate single-cell omics data of various modalities (RNA, ATAC) and encompassing multiple cell types and contexts (such as tissue inflammation, cellular development stages, gene perturbations), with disease GWAS data to decode the role of enhancer regulation in linking GWAS variants to target genes, to map GWAS variants to function by leveraging the genetic variation of multiple molecular phenotypes, and to assess the role of context-specific activity of genes and genomic elements in shaping up the genetic architecture of the disease.